Defining and Targeting Lineage Transition Programs Operative in AR Pathway Independent Prostate Cancer

PROJECT SUMMARY/ABSTRACT
The Androgen Receptor (AR) may be the earliest known example of a lineage oncogene: a master regulator of
cell survival and growth to which neoplastic cells derived from prostate epithelium are addicted. Recognizing this
unique feature, concerted efforts have focused on developing therapeutics capable of suppressing AR signaling.
Emerging strategies, mirroring successes in treatment for infectious diseases, will eventually deploy
combinations of drugs that will likely extinguish AR signaling, an event that may cure a subset of prostate
cancers. However, the plasticity of carcinomas, in part generated by highly unstable genomes, suggests that
prostate cancers are likely to emerge from this therapeutic pressure with a phenotype/genotype that is entirely
independent of AR signaling. This proposal is designed to anticipate that combinatorial AR pathway inhibition
will contribute to cell plasticity and select for subpopulations of resistant tumor cells that are completely
independent of AR signaling and do not exhibit neuroendocrine characteristics. We will test the hypothesis that
AR Pathway-Independent Prostate Cancers (APIPC) activate, and are dependent upon, a limited set of specific
survival and growth regulatory pathways that are regulated via de-repressed feedback loops and/or
genetic/epigenetic alterations in specific oncogenic networks.
Our Aims and strategies are as follows:
Specific Aim 1: Determine the mechanisms by which fibroblast growth factor (FGF) signaling promotes the
progression of AR-dependent PC to AR-null APIPC and assess outcomes of FGF-targeted
therapeutics. Cell lines and PDX models of disease representing a spectrum of AR-dependent
and AR-independent lines will be evaluated.
Specific Aim 2: Determine the mechanisms contributing to FGF pathway activation in APIPC. We will utilize
relevant in vivo model systems and biospecimens to determine genomic and epigenomic
mechanism(s) that activate FGF signaling and determine how the FGF pathway promotes
adverse prostate cancer phenotypes.
Specific Aim 3: Identify and target mechanisms of resistance to FGF pathway inhibition and to other drivers
of prostate cancer lineage plasticity. We will evaluate relevant model systems and human
biospecimens for the heterogeneity and diversity of mechanisms contributing to tumor cell
plasticity, and assess the effectiveness of therapeutics that intercept, reverse or inhibit
emerging drivers.
In order for effective therapeutics to be developed that can adequately address this new class of malignancy,
the pathways utilized by APIPC must first be clearly defined; this project aims to elucidate those underlying
mechanisms.

Public health relevance
PROJECT NARRATIVE This relevance of this proposal centers on illuminating the mechanisms by which a rare but highly-lethal type of metastatic prostate cancer – known as Androgen Receptor Pathway-Independent Prostate Cancers (APIPC) – is able to flourish and progress. The incidence of this form of the disease is increasing due to the widespread use of potent AR pathway inhibitors, and represents a significant challenge in terms of clinical management. Successful completion of this project will yield actionable targets and potential therapeutics.